Preclinical Characterization of CRAC Channel Inhibitors for the Treatment of Alzheimer's Disease

Vivreon Biosciences, LLC
4940 Carroll Canyon Rd., Ste. 110
San Diego, CA 92121
[email]
Vivreon Biosciences
Technical Assistance and Late-Stage Development, PAR-23-219, NOT-AG-23-048, AG061995
Preclinical Characterization of CRAC Channel Inhibitors for the Treatment of Alzheimer's Disease
Project Summary
Delaying onset of Alzheimer’s Disease (AD) by 5 years would reduce US healthcare costs by one third,
however, and there is an urgent need to develop therapeutics that can slow disease progression. Alongside
accumulation of improperly aggregated proteins such as amyloidb (Ab), synapse loss is also driven by neurotoxic
inflammation of activated brain microglia. Productive microglial responses are normally transient, effectively
clearing infectious agents or cellular debris, and involve phagocytic and other reparative processes. A therapy
that restores the balance of reparative versus damaging neurotoxic microglial responses is hypothesized to
reduce synaptic damage and slow disease progression.
The Ca2+ Release-Activated Ca2+ (CRAC) channel is activated by multiple receptors on microglia, and
downstream signaling drives a multiplicity of biochemical and gene expression events typical of damaging
neurotoxic inflammation driven by the NFAT promoter. Indeed, the CRAC channel, is supported as a drug target
for AD therapy by genome-wide association study (GWAS) evidence. Vivreon’s long-term goal is to develop a
novel CRAC channel therapeutic to delay cognitive decline in persons with AD by targeting microglia. AD risk
genes TREM2 and PLCγ2 function in the same microglial Ca2+ signaling pathway and TREM2 mutant microglia
have exacerbated CRAC signaling. We hypothesize that Aβ and cell death-associated biomolecules like ADP
drive sustained Ca2+ signaling by microglial CRAC channels, resulting in AD pathology. Vivreon CRAC channel
modulators selectively inhibit neurotoxic microglial inflammation while promoting beneficial phagocytic and
survival functions without dampening the beneficial immune response to a viral challenge. Vivreon is currently
conducting pre-development/candidate validation studies as part of grant AG061995. We now seek
supplemental funding to advance our lead brain-penetrant CRAC-modulating compound, VV8325, into
Investigational New Drug (IND)-enabling studies. Specifically, Vivreon seeks CRP supplemental funding to
accomplish the 3 following:
· Chemistry, Manufacturing, and Control (CMC) activities
· IND-enabling Good Laboratory Practice (GLP) toxicity, safety pharmacology, and genotoxicity
· Technical assistance towards IND filing
These specific aims are complementary to, and will run concurrently with, the ongoing Phase 2 SBIR.
CMC studies will entail process and analytical R&D, method quantification, production of a 500 g batch and
polymorph and stability studies. GLP studies will include genetic toxicology, general toxicology, and safety
pharmacology. We will develop our IP and regulatory strategy in partnership with a development consultant, and
assemble the documentation needed in Standard for Exchange of Nonclinical Data (SEND) dataset to support
IND filing. Completion of grant milestones will generate the data necessary to de-risk our novel AD therapeutic
program and attract third-party investment to fund first-in-human (FIH) studies.

Public health relevance
Vivreon Biosciences, LLC 4940 Carroll Canyon Rd., Ste. 110 San Diego, CA 92121 [email] Vivreon Biosciences Technical Assistance and Late-Stage Development, PAR-23-219, NOT-AG-23-048, AG061995 Preclinical Characterization of CRAC Channel Inhibitors for the Treatment of Alzheimer's Disease Project Narrative Alzheimer’s Disease (AD) is a complex, age-related disorder with many underlying pathologies including amyloidopathy, tauopathy, and neuroinflammation. This project will advance Vivreon Biosciences’ lead drug candidate for reduction of neurotoxic inflammation that contributes to the rate and extent of progression of AD. A successfully completed project will lead to private funding that will allow Vivreon to carry the drug candidate forward through human clinical trials and eventually to market as a disease-modifying therapy for AD.